Project 3: Translating Pulmonary Xenotransplantation

ABSTRACT
Translating Pulmonary Xenotransplantation
The barriers that prevent use of pig lungs to save human lives remain incompletely understood.
Although we have accomplished significant prolongation of in vivo lung xenograft recipient survival over the
past decade, the combinations of pig genetics and treatment strategies tested to date have not yet yielded
consistent survival beyond 5-7 days. Our extensive prior work in the ex vivo lung perfusion model has
identified multiple mechanisms that participate in lung xenograft injury. Specifically, we have shown protective
effects are associated with 1) removal of Gal1,3αGal and other carbohydrate targets of preformed human anti-
pig antibodies; 2) increased dose of complement pathway regulatory gene and protein expression,
underscoring the role of complement; 3) expression of hTBM, particularly in association with hEPCR,
demonstrating partial protection from thrombodysregulation; 4) HLA-E/β2µ, implicating NK cells; and 5)
humanization of porcine von Willebrands Factor (h*pvWF), which reduces non-physiologic ligation of human
platelet GP1B. Important roles for 6) the self-recognition receptor, hCD47, to inhibit macrophage/monocyte-
driven lung inflammation, 7) pulmonary intravascular macrophages, 8) and anti-inflammatory agents such as
α1 antitrypsin have also been revealed by work and that of others. We have tested lungs in vivo from pigs with
a wide variety of combinations of gene modifications and adjuvant anti-inflammatory treatment strategies.
Using 10-GE (TKO.GHRKO.hCD46.hCD55.hTBM.hEPCR.hCD47.HO-1), we find that survival is shortened and
inflammation is more intense than in association with GalTKO.hCD46.h*pvWF pig lungs, providing additional
evidence to data from heart and kidney studies that the TKO gene construct (and specifically the CMAHKO)
unveils a ‘4th antigen’ against which baboons (and other NHP) mount strong innate immune responses. Here
we propose to test 3 candidate gene modifications to the 10GE pig, each of which is likely to contribute to
overcome the current barrier to sustained life-supporting lung xenograft function. 1) By omitting the CMAH KO
from the gene construct, we predict that ‘9-GE’ lungs will avoid injury driven by preformed antibody against the
as-yet-unidentified ‘4th antigen’ unveiled by that gene modification. 2) HLA-E expression on 9- or 10-GE lungs
should reduce NK cell activation and injury. 3) Reduced platelet activation and thrombodysregulation are
expected in association with h*pvWF modification to 9- or 10-GE lungs. By testing each of these pig
phenotypes in parallel in vivo, with left single lung transplantation into a baboon, and by ex vivo perfusion of
the right lung using human blood, and characterizing the innate and adaptive immune responses with robust
support from the Pathology/Mechanistic Core, we expect to expand understanding of the residual mechanisms
driving lung xenograft injury. Surveillance for opportunistic infections (Microbiology Core) will be conducted as
for the other Projects to assess clinically applicable diagnostic tools. Results from this Project, within the
Program, are likely to reveal organ-specific barriers and clinically translatable therapeutic opportunities.

Public health relevance
PROJECT NARRATIVE Many patients with lung failure waiting for a transplant die each day because of the lack of donor lungs. If pig lungs could be used to increase the number of transplants every year, many lives would be saved. These studies will explore ways to achieve successful pig-to-human lung xenotransplantation.